A Multi-Site Feasibility Trial of Embedded Emergency Department Physical Therapy for Back Pain

PROJECT SUMMARY
Low back pain affects nearly half of all Americans per year and accounts for nearly three million annual
emergency department (ED) visits. In nearly two thirds of these visits, an opioid medication is administered or
prescribed, making low back pain the most common reason for opioid prescribing in the emergency care
setting and in the general population. Despite this medication-based treatment strategy, many patients with low
back pain continue to do poorly after an ED visit: nearly half of all patients report persistent functional
impairment at three months, and one in five patients report continued opioid use. Clearly there is a need for an
alternative treatment approach that improves low back pain symptoms and reduces the need to use opioid
medications. Multiple randomized trials have demonstrated that early referral to physical therapy in the
outpatient setting is efficacious for low back pain, but it is unknown whether these same benefits can be
extended to patients evaluated by physical therapists in ED settings – which differ from clinic-based settings
due to the acuity/severity of pain necessitating an emergency visit and accompanying psychosocial stressors.
We previously developed, pilot-tested, and refined an “embedded” ED physical therapy intervention protocol
for low back pain, in which a dedicated physical therapist is placed on the primary ED treatment team to
evaluate and treat patients with low back pain early in their overall treatment course. The ED physical therapist
uses a diagnosis-driven treatment protocol to deliver an integrated mind and body intervention grounded in a
biopsychosocial model of pain. In our preliminary work at a single site, ED patients that received ED physical
therapy, as compared to usual care, reported greater improvements in pain-related functioning and less use of
opioid medications over three months of follow-up. We now seek to evaluate whether this embedded ED
physical therapy intervention can be feasibly delivered with high fidelity at multiple other sites and demonstrate
that we can consistently collect electronic health record and patient-reported outcomes of interest. We will then
use the findings from this multi-site feasibility trial to justify and inform a full-scale multi-site cluster-randomized
clinical trial of an embedded ED physical therapy care model for low back pain.

Public health relevance
PROJECT NARRATIVE Low back pain affects almost half of all Americans per year and is the most common reason for which opioids are prescribed. Multiple randomized controlled trials have demonstrated that early referral to physical therapy in the outpatient setting is efficacious for low back pain, but it is unknown whether these same benefits can be extended to patients evaluated by physical therapists in emergency department settings. This multi-site feasibility trial will test the feasibility and fidelity of an “embedded” emergency department physical therapy intervention for low back pain in preparation for a future full-scale multi-site trial.